Multi-modal functional health assessment and intervention for individuals experiencing cognitive decline

PROJECT SUMMARY / ABSTRACT
The world's population is aging and the increasing number of older adults with Alzheimer's disease and
related dementias (ADRDs) is a challenge our society must address. While the future of healthcare availability
and quality of services seems uncertain, at the same time advances in pervasive computing and intelligent
embedded systems provides innovative strategies to meet these needs. One particular need which technology
can help address is assessment and assistance with a person's functional performance. The long-term goal of
this work is to develop technologies that will improve the independent functioning and quality of life of
individuals with functional limitations (particularly individuals with ADRDs) and reduce their reliance on
caregivers. The primary objective of this application is to develop a multi-modal sensor-based approach to
automate functional health assessment and assistance with everyday activities. Building on our prior
collaborative work, our approach will be to collect and fuse multi-modal functional performance data from
ambient sensors, mobile sensors, free text, and assessment apps (Aim 1). This fused “human behaviorome” will
provide a basis, together with observation-based ground truth, for automated functional assessment and
validation of each component technology, including the use of compensatory strategies, through in-person
observation and through video recording of typical daily activities and strategies (Aim 2). Finally, using
iterative, user-centered assessment of prompt-based assistance, we will evaluate the ability of activity
segmentation and forecasting techniques to provide automated support for activity initiation and accurate
completion of everyday activities (Aim 3). The proposed contributions are significant because they will provide
insights on functional health revealed within a person's everyday environment that have not been investigated
in prior work. The results can also help to extend functional independence through real-time assistance, while
the outcomes can assist family planning, provision of care, and design of real-world and lab-based measures of
functional performance. This work is important because of the increasing number of older individuals
experiencing cognitive and functional limitations due to chronic health conditions. Furthermore, they address
the need for individuals to remain functionally independent as long as possible in their own homes, thereby
improving quality of life and reducing health care costs.

Public health relevance
PROJECT NARRATIVE We propose to design and pilot test a multi-modal sensor-based approach to automate functional health assessment and provide assistance with everyday activities for individuals with Alzheimer's disease and related dementias (ADRDs). This work will demonstrate that intelligent technologies can be used in real-world settings for functional health assessment and intervention. This research is relevant to public health because these technologies can extend the functional independence of our aging society through technology-assisted health self-management, reduce caregiver burden and improve quality of life.